Best of AGA FORWARD - Fostering Opportunities Resulting in Workforce and Research Diversity

PROJECT ABSTRACT
For more than 20 years, the American Gastroenterological Association (AGA) has successfully executed
NIDDK-funded efforts to promote the recruitment and retention of underrepresented physician-scientists in
gastroenterology. Our Fostering Opportunities Resulting in Workforce and Research Diversity
(FORWARD) Program was first funded in 2018 and has successfully recruited and trained numerous senior
and near-peer mentors who have effectively guided early-stage professionals toward grant funding, academic
promotions, and leadership roles within AGA committees.
The current FORWARD Program enrolls and trains cohorts of 14 scholars over an 18-month training period.
However, since its inception, FORWARD has become a top-rated program for training for early-stage
underrepresented gastroenterologists with a proven track record of successful career outcomes among
program alumni. Thus, interest from the gastroenterology community has far exceeded the availability of
training slots, creating a new challenge for AGA in 2024.
Our proposed supplemental application, the Best of FORWARD immersion experience, is designed to
disseminate the most impactful aspects of the longitudinal FORWARD experience for a larger audience that
cannot be accommodated through the parent program. Similar to the parent program, our overall objective is
to overcome a primary impediment to diversifying the biomedical workforce -- accessible and effective
mentorship. We plan to accomplish our objective through four specific aims:
1) Enhance mentorship through access to race and ethnicity-concordant near-peer and senior mentors.
2) Broaden academic research skills.
3) Strengthen leadership skills with a focus on team science and lab management.
4) Establish a sustainable network of underrepresented physician-scientists and mentors through a digital
community within a mobile app.

Public health relevance
PROJECT NARRATIVE The Best of FORWARD Program will translate aspects of the American Gastroenterological Association’s FORWARD Program for a broader audience through a multi-faceted approach to mentorship and peer networking that will enhance the career development of underrepresented physician-scientists and equip them with the skills needed to be successful in the biomedical workforce. Our long-term goal is to enhance the diversity of the biomedical science research workforce studying digestive health and prepare individuals to assume leadership positions within our professional association and in academic medicine. The Best of FORWARD Program will provide greater access to mentoring, bolster research and leadership skills, and address diversity, equity, inclusion, and access by conducting skill-building in an intensive immersion experience while maintaining sustainable relationships with mentors and accessing education via mobile-app technology that allows for flexible and accessible mentor-mentee engagement.